EFFECTS OF INSULIN-LIKE GROWTH FACTOR I IN OSTEOBLAST FUNCTION OF NORMAL ELDERLY

To determine whether there is an age-related defect in osteoblast function and to explore what the mechanism of this possible defect might be.